Area C Pathogenesis and Diagnosis

PROGRAM PROJECT 3 [PP3]: Advancing Clinical and Entomological Surveillance (ACES)
through emergent diagnostic and translational systems biology platforms to address emerging
issues viz. asymptomatic malaria and non-falciparum malaria transmission in the context of
malaria elimination and eradication (MEE).
ABSTRACT/SUMMARY
Progress toward the global target set out in the WHO Global Technical Strategy for malaria 2016-2030 to reduce
malaria case incidence and mortality rates by at least 90% by 2030― against a 2015 baseline— has stalled. A
significant challenge to effectively identifying and treating malaria infection is targeting asymptomatic cases –
important parasite reservoirs contributing to sustained transmission. Substantial emphasis needs to be placed
on identifying subclinical P. falciparum (Pf) infection to reach global elimination goals, especially considering
difficulties that are arising from increasing failure rates of rapid diagnostic tests (RDT) – and thus increasing
false-positive rates – for PfHRP2-based RDTs due to strains with pfhrp2/3 gene deletions, as well as a
considerable lack of sensitive field-deployable diagnostic tools for non-falciparum malaria (NFM), which includes
P. vivax (Pv), P. ovale curtisi (Poc), P. ovale wallikeri (Pow), and P. malariae (Pm). To better understand the
epidemiological factors contributing to subclinical Pf and/or NFM infections and their role in residual malaria
transmission, Plasmodium species detection is paramount, as it can influence treatment regimens and potentially
guide control and intervention policy. While malaria RDTs and the ‘gold standard’ light microscopy remain
important, the requirement to quantify the subclinical parasite reservoir alongside the detection of key mutations
necessitates the use of molecular methods. Going beyond the molecular approach, other ‘omics’ approaches
may be more powerful in providing new insight into malaria transmission biology. The overarching hypothesis to
be explored in PP3 is to investigate the use of innovative tailored multiomics solutions to address the
considerable challenge of accurately detecting and diagnosing subclinical Pf and NFM infections. Leveraging
our existing bank of saliva, whole blood, dried blood spots, and liquid blood spots, the project will seek to test,
define, and validate a suite of novel diagnostic tests to detect, quantify and characterize asymptomatic Pf
infection and NFM. T
his Émergents ICEMR program project seeks to: Aim PP3.1. Implementation of non-
invasive rapid tests for identifying individuals (adults and children) and thereby quantifying the parasite
reservoir in the human population contributing to residual transmission; Aim PP3.2. Developing and
validating a quantitative dried blood spot into direct, no extraction qPCR diagnostic platform for Pf, Pv,
Po(w), Po(c), and Pm; and Aim PP.3.3. Dissecting the biology of asymptomatic Pf, NFM and mixed
infections viz. malaria transmission. Key outcomes of PP3 will be to generate prevalence data for subclinical
Pf infections in Nigeria through retrospective analyses of saliva samples using the SMAART-1 lateral flow test,
develop a rapid cost-effective process of molecularly screening for Plasmodium infection in qDBS from clinical
samples, and collected mosquito samples, and establish a novel, deployable lipidomic analytical platforms for
interrogating human host profiles that facilitate NFM transmission, as well as assessing species, insecticide
resistance and infection status.

Public health relevance
PROGRAM PROJECT 3 [PP3]: Advancing Clinical and Entomological Surveillance (ACES) through emergent diagnostic and translational systems biology platforms to address emerging issues viz. asymptomatic malaria and non-falciparum malaria transmission in the context of malaria elimination and eradication (MEE). PROJECT NARRATIVE Malaria remains a global health crisis affecting over 241 million people and leading to 627,000 deaths, mostly in children. New tools are necessary to address emerging and drug-resistant strains, the complexity of mixed infections, invasive mosquito species, and the control of insecticide resistant mosquito vectors in support of the goal for malaria elimination. Program Project 3 of the West-Central Africa Enhancing Malaria Epidemiology Research through Genomics & Translational Systems biology (Émergents) International Center of Excellence in Malaria Research (ICEMR) is focused on Advancing Clinical and Entomological Surveillance (ACES) through emergent diagnostic and translational systems biology platforms to address emerging issues viz. asymptomatic malaria and non-falciparum malaria transmission in the context of malaria elimination and eradication (MEE).